Toward smart personalized electrotherapy for enhanced healing of ischemic wounds

Non-healing ischemic wounds are a major problem for Veterans with physical impairment and/or disability.
These chronic wounds cause significant pain and disability and occur at an alarmingly high frequency in at-risk
Veteran populations cared for by the Veterans Healthcare Administration (VHA). The use of electrical
stimulation (ES) for ischemic wound therapy has long been known but the outcomes have been variable. In
previous work we developed an untethered electronic bandage with all the components of a surface stimulation
system mounted on a flexible substrate. We systematically investigated the effects of a range of clinically
relevant ES and found two paradigms that significantly enhanced healing in a rat ischemic wound model. One
of these paradigms was also found to significantly reduce wound infection in an acute preclinical model of
clinically relevant large wounds.
The project will provide translational development and testing in a relevant large animal model of the Smart
Modular Adaptive Electrotherapy Delivery System (SmartMAEDS) to provide both treatment and remote
monitoring of chronic ischemic wounds. The patented SmartMAEDS system is an innovative approach
incorporating both ES and real-time wound monitoring. SmartMAEDS will reduce cost and improve healing
efficacy by providing therapeutic ES in a bandage that does not need to be repositioned for each treatment
session thus improving uniformity of ES therapy. SmartMAEDS also provides innovative remote monitoring
capabilities to reduce unnecessary dressing changes. By assessing wound bed impedance, SmartMAEDS will
monitor progress towards healing. SmartMAEDS will also check for early indications of infection by monitoring
wound bed temperature.
Development of the Smart MAEDS system will include refinement of the disposable flexible substrate and the
reusable stimulation/control module. Our collaborators at Koronis Biomedical Technologies will develop two
software applications to manage SmartMAEDS wireless communication. StimCheck will run in the background
providing instant feedback on connection status. StimMANAGE will provide a clinical user interface for real
time monitoring of wound status including graphical history and trends, enabling the clinician to control and
modify therapy as needed. We will evaluate SmartMAEDS in a pig model of ischemic wounds of a clinically
relevant size. ES paradigms shown to enhance healing and reduce infection in our preliminary work will be
assessed. Quantitative non-destructive in vivo assessment methodologies will include monitoring of tissue
ischemia and progressive wound healing using transcutaneous blood gas levels and serial 3D digital
photography. Wound status at fixed timepoints will be evaluated using histology, histomorphometry,
immunohistochemistry and rt-PCR to determine the expression of over 80 genes involved in all stages of
wound healing. Planktonic bacterial infection status, biofilm formation and microbial community profiling will
also be evaluated following protocols developed in our previous work.
Prototype SmartMAEDS devices have been developed under the Advanced Platform Technology Center
Quality Systems/Design Control-program. A multidisciplinary clinical expert review panel will ensure that this
new approach to chronic wound therapy will be highly acceptable to clinical users. The effective treatment of
chronic wounds is integral to providing the highest standards of health care for Veterans. Translational pre-
clinical evaluation of SmartMAEDS using a valid animal model will provide a strong foundation for effective
translation to clinical care. Our collaboration with Koronis Biomedical Technologies will support pre-market
development of a user-friendly bandage that can be worn for up to five days, concurrently delivering treatment
and monitoring wound status. SmartMAEDS will be a disruptive value-driven technology in the wound care
market at lower cost to VHA providing increased clinical benefit for Veterans with chronic wounds.

Public health relevance
Chronic ischemic wounds don't heal normally, causing significant pain and disability for many Veterans. Electrical stimulation (ES) is the only adjunctive treatment recommended for these severe ischemic wounds but has variable outcomes. We have developed and systematically tested a wearable untethered bandage enabling ES therapy to be delivered safely outside the clinic. We identified effective ES therapeutic paradigms to enhance healing and decrease wound infection. The next step, proposed in the current study, is to carry out preclinical translational development and testing of the Smart Modular Adaptive Electrotherapy Delivery System (SmartMAEDS) to concurrently treat and monitor chronic ischemic wounds. SmartMAEDS enables real-time remote monitoring of wound status, minimizing unnecessary dressing changes and wound bed disruption, improving healing outcomes and increasing patient safety. SmartMAEDS will reduce the burden of clinic attendance and the costs of delivering excellence in care to Veterans with chronic ischemic wounds.